Decoding the functional pleiotropy of IL-20Rβ ligands in inflammation and tumorigenesis

Robert A. Saxton | K22 (PAR-18-467) | Project Summary / Abstract
Although inflammation is essential for protecting organisms against infection, excessive or chronic
inflammation is also associated with an increased risk of certain cancers. This is particularly true at epithelial
barriers such as the colonic mucosa in the gastrointestinal (GI) tract, which are in frequent contact with the
external environment and therefore particularly susceptible to damaging inflammatory responses. Indeed, over
20% of patients with inflammatory bowel disease (IBD) will go on to develop colitis-associated cancer (CAC).
Moreover, most therapeutic options for autoinflammatory diseases like IBD involve the use of
immunosuppressive drugs, which may also increase tumor incidence due to reduced immunosurveillance.
An alternative approach is to exploit natural mechanisms of tissue protection and repair in order to
reduce tumor-promoting inflammation without suppressing anti-tumor immune responses. Recently, several
members of the IL-20 cytokine family have been shown to be upregulated in both IBD and GI cancers, but their
functional roles in these contexts are not fully understood. This includes the cytokines IL-19, IL-20, and IL-24,
all of which signal through the shared receptor subunit IL-20Rβ. However, whether this upregulation drives
disease pathology or reflects a beneficial but insufficient homeostatic response remains unclear. This is largely
due to the combinatorial and interconnected nature of receptor sharing within this family, resulting in a high
degree of functional pleiotropy and redundancy that hinders experimental interrogation of these pathways.
In this project, we will employ structure-guided protein engineering to deconvolute the pleiotropic
functions of IL-20Rβ ligands in inflammation-associated colon cancer. We will first use a combination of
directed evolution and structure-based rational protein design to develop a pharmacological toolkit, comprising
IL-20 receptor agonists and antagonists with altered receptor specificities, allowing us to selectively modulate
the activity of individual IL-20Rβ ligands. We will then use these tools in vivo to probe the effect of these
engineered proteins in the development, progression, and gene expression changes over the course of colitis
induction and tumor progression, using the well-established AOM/DSS mouse model of CAC. Together, these
studies will provide important insights into the protective and pathogenic functions of distinct IL-20Rβ ligands in
CAC, while also directly testing the therapeutic potential of our engineered cytokine variants in the prevention
of inflammation associated cancer.

Public health relevance
Robert A. Saxton | K22 (PAR-18-467) | Project Narrative IL-20 family cytokines are pleiotropic immune cell-derived factors that are upregulated in inflammation and have been implicated in the occurrence of inflammation associated tumorigenesis. The proposed research aims to interrogate the diverse functions of these cytokines by engineering IL-20 receptor agonists with altered receptor specificity and signaling profiles, enabling us to deconvolute their functional effects in a mouse model of colitis-associated cancer. These studies will provide insights into the therapeutic potential of these engineered cytokines in the treatment and prevention of inflammation-associated cancers.